Adaptive Neurostimulation to Restore Sleep in Parkinson's Disease: An Investigation of STN LFP Biomarkers In Sleep Dysregulation and Repair

Project Summary
Parkinson’s disease (PD) is a neurodegenerative disorder that leads to both motor and non-motor symptoms.
While there is as yet no cure for PD, medical and surgical therapies have been developed that effectively target
the motor symptoms of PD. Non-motor symptoms are far more disabling for patients, precede the onset of motor
symptoms by a decade, are more insidious in onset, have been less apparent to clinicians, and are less
effectively treated. Sleep dysfunction is oftentimes the most burdensome of the non-motor symptoms—both to
patients and to their caregivers—is pervasive in patients with PD, and includes sleep fragmentation, insomnia,
excessive daytime sleepiness, REM behavioral disorder, and restless leg syndrome. There are limited options
for treating sleep dysfunction in PD, and the mainstay of therapy is the use of agents that mask the sleep
disturbance—such as the sedative-hypnotic drugs—without addressing the underlying mechanisms.
Although much attention has been devoted to PD motor symptoms, sleep dysfunction in PD has largely been
ignored. Sleep is vital to homeostasis, cognition, and nervous system repair, and the dysfunctional sleep
accompanying PD adversely affects both motor and non-motor symptoms, resulting in diminished quality of life,
impairments in mood and behavior, and increased morbidity and mortality. Patients with PD who demonstrate
significant motor fluctuations and dyskinesia are considered for subthalamic nucleus (STN) deep brain
stimulation (DBS) surgery. Although STN-DBS is routinely used to treat PD motor symptoms, several studies
have reported that STN-DBS also provides benefit for sleep dysregulation through normalization of sleep
architecture. Additionally, local field potentials recorded from STN DBS electrodes implanted for the treatment
of PD, have led to the identification of unique spectral patterns in STN oscillatory activity that correlate with
distinct sleep cycles, offering insight into sleep dysregulation. Building on this work, and in response to RFA-NS-
18-023, this proposal will leverage novel investigational DBS battery technology (RC+S Summit System;
Medtronic) that allows the exploration of sleep biomarkers and prototyping of closed-loop stimulation algorithms,
to test the hypothesis that STN—a highly interconnected node within the basal ganglia—contributes to the
regulation and disruption of human sleep behavior and can be manipulated for therapeutic advantage.
Specifically, in PD patients undergoing STN-DBS, we will determine whether STN oscillations correlate with
sleep stage transitions, then construct and evaluate sensing and adaptive stimulation paradigms that allow
ongoing sleep-stage identification, and induce through adaptive stimulation an increase in duration of sleep
stages associated with restorative sleep. This work will lead to findings that address a currently unmet
clinical need, and relevant to the mission of NINDS and the BRAIN Initiative, will evaluate the use of
adaptive stimulation of the STN in PD patients for the treatment of sleep dysfunction.

Public health relevance
Project Narrative With this study, we will gain a better understanding of how the basal ganglia contribute to pathological sleep behavior in humans. This information will be used to understand better how the brain regulates sleep and how we can intervene therapeutically in sleep regulation in order to develop new therapies for sleep disorders both for patients with Parkinson’s disease and for other populations suffering from dysfunctional sleep. In addition, we will use these results to improve the accuracy of sleep dysfunction diagnoses, enabling the application of existing therapies more appropriately, and the development of novel therapies.